Integrated Microscopy Facility

PROJECT SUMMARY/ABSTRACT - INTEGRATED MICROSCOPY FACILITY (IMF)
Microscopy is an essential technology for cancer investigators, providing imaging to test hypotheses about
physiologic processes at the whole-animal, organ, cell, and now at near-molecular level. The Integrated
Microscopy Facility (IMF) provides state-of-the-art imaging capabilities to University of Chicago Medicine
Comprehensive Cancer Center (UCCCC) investigators and others. The major objective of the IMF is to
provide imaging expertise and instrumentation to advance investigator-driven basic and translational cancer
research and foster the research output of the investigators. The IMF offers all major light and confocal laser
microscopy instrumentation (including wide-field apparatuses), in addition to super-resolution technologies
(e.g., stimulated emission depletion or STED, localization, structured light). In the reporting period, IMF
supported 79 unique UCCCC members (47% MMC, 9% CPC, 22% IC, 18% CET, 5% ZY), with 179 peer-
reviewed cancer-related federal grants and 103 peer-reviewed publications (48% in journals with impact
factor ≥10).
A key goal for the IMF is to keep operating costs within reach of all UCCCC laboratories, accordingly, IMF
has made over $1.8M in equipment upgrades since 2018, all with institutional funds. Future efforts are aimed
at maintaining the high-quality services offered. To meet evolving demands, IMF will continually evaluate
rapidly evolving technologies to make state of the art tools available for the diverse needs of UCCCC
investigators. Computational approaches (e.g., “deep learning” techniques) likewise are now enhancing data
gathering and analyses. This Core will strive to match the diverse tools available to the diverse needs of the
UCCCC Investigators.